Investigation of the tubulin autoregulatory response at the mechanistic level and in the human neuron

Project Summary/Abstract
Microtubules (MTs) are dynamic cytoskeletal structures that mediate diverse processes from cell division to
organelle transport to cell morphology and are built by self-assembly of αβ-tubulin heterodimers. Studies in vitro
readily emphasize the direct relationship between the concentration of these heterodimers and MT abundance
and dynamics. In cells, where MT structure and dynamics are further tuned by microtubule-associated proteins
and modifying enzymes, the soluble tubulin pool is easily overlooked. Cells, however, closely monitor and buffer
against perturbation to this pool through a unique phenomenon known as tubulin autoregulation whereby free
tubulin governs the stability of its own transcript. Despite initial characterization over 40 years ago, the
mechanistic basis of tubulin autoregulation, its molecular effectors (ex. the sensor of soluble tubulin or the RNA
decay factor) and the functional implications of tubulin autoregulation in cellular homeostasis remain largely
unknown. Independent studies within the last year identified the protein TTC5 as both a key mediator of tubulin
autoregulation and an underlying cause of intellectual disability with cerebral atrophy, providing a valuable
molecular inroad into the autoregulatory mechanism and a powerful rationale for characterizing its role within the
nervous system. I hypothesize that neurons, as highly-polarized cells scaffolded structurally and functionally by
MTs, are uniquely sensitive to dysregulation of the soluble tubulin pool. Here, I tackle tubulin autoregulation at
multiple scales, in highly-mechanistic detail and in the disease-relevant context of the human neuron. To dissect
tubulin autoregulation mechanistically (Aim 1), I will deploy TTC5 and tubulin as molecular handles to isolate
additional effectors using proteomic and biochemical methods and will leverage bioinformatics, RNA reporter
design and manipulation of RNA decay pathways to identify functional features within tubulin mRNAs using
simple cell lines. To interrogate TTC5 and tubulin autoregulation functionally (Aim 2), I will utilize CRISPR
methodologies to knock-down TTC5 in a human iPSC-derived neuron model. Using live-cell imaging, I will
assess the impact of loss of TTC5 and tubulin autoregulation on neuronal morphology, MT dynamics and
transport across neuronal differentiation, homeostasis and in response to and recovery from diverse stresses
such as drug-induced depolymerization and axotomy. Overall, this work will address unanswered questions
in fundamental microtubule biology and dissect the mechanism of tubulin autoregulation in
neurophysiology and pathology. The proposed work represents an entirely new field of study for me and new
direction for the lab, establishing independence while integrating the diverse expertise of my sponsors and
collaborators in microtubule (Dr. Roll-Mecak), RNA (Dr. Hogg) biology and neurological disease (Dr. Ward).
Through their mentorship, I will acquire excellent training in biochemistry, bioinformatics, live-cell imaging and
use of neuronal cell culture models and establish the scientific basis for my own research program studying
microtubule regulation from fundamental mechanisms to disease-relevant, cell-type specific contexts.

Public health relevance
Project Narrative Cellular architecture and function are highly dependent on the integrity of the microtubule cytoskeleton whose assembly is driven by self-polymerization of its constituent α- and β-tubulin subunits. The critical importance of microtubule maintenance is evidenced by the unique feedback mechanism the cell has in place to buffer against defects in the balance between the soluble pool and polymer, a process termed tubulin autoregulation. This proposal aims to both dissect the mechanism and molecular effectors of this autoregulation and characterize the functional importance of this pathway in the human neuron where microtubule cytoskeletal defects often underlie neurodevelopmental and neurodegenerative disease.